Optimizing Deceased Donor Kidney Allocation Using Decision Science

PROJECT SUMMARY/ABSTRACT
Although kidney transplantation provides better survival, quality of life, and long-term cost compared to
maintenance dialysis, the majority of patients with end-stage kidney disease in the United States will never
receive a transplant due to a severe shortage of donated kidneys. In response to this shortage, there has been
an increasing emphasis on expanding the use of less-than-ideal deceased donor kidneys, which still provide
survival and quality of life benefits over extended waiting time for a higher quality kidney. Despite efforts to
increase the aggressiveness of organ recovery and utilization, thousands of likely transplantable kidneys are not
recovered or discarded after recovery each year, primarily due to quality concerns. We and others have shown
that clinicians’ subjective assessments of organ quality are often too conservative, and that cognitive heuristics
impact perception or organ quality and likelihood of organ utilization. A key target for improving perceptions of
organ quality is therefore to use decision science to improve the presentation of information during organ offers.
The goal of the proposed project is to understand how surgeons prioritize and consume information during organ
offer decisions, then use a mechanisms-based approach to target cognitive heuristics that favor inappropriate
organ offer refusal. We will begin with improving the presentation of the results of procurement biopsies. Despite
reliance on findings from these biopsies— which are the most common reason for deceased donor kidney
discard— their independent prognostic capability is limited as they are currently performed. We hypothesize that
our approach will enable standardization of procurement biopsy presentation in a manner that reduces
deleterious impacts on organ offer acceptance.
To complete the proposed project and acquire the skills needed for development into an independent investigator
in the field of kidney transplantation, Dr. Husain will work closely with a multidisciplinary team of mentors and
advisors, led by Dr. Sumit Mohan, to develop research expertise in the areas of interventional and prospective
study design, decision making science & human-centered design, kidney transplant epidemiology, and research
dissemination & professional development. Upon completion of this project, he will have the scientific and
research expertise needed to be a grant-supported independent investigator in this field.

Public health relevance
PROJECT NARRATIVE Kidney transplantation provides the best survival and quality of life for patients with kidney failure, but there is a shortage of kidneys available for transplantation in the United States. This organ shortage necessitates the use of some deceased donor kidneys with less-than-ideal characteristics, and the safe use of these kidneys requires accurate and reliable assessments of organ quality; however, the current presentation of clinical data leads to suboptimal decision making that discourages the use of transplantable marginal kidneys. This project aims to use decision making science to improve the way that this data is presented, starting with deceased donor kidney biopsy results, in order to improve the utilization of kidneys from the expanded donor and organ pool.